Regulation of Differentiation of Pediatric Embryonal Tumors- Neuroblastoma

Specific Aim 1. To identify key differentiation genes and characterize their molecular mechanisms of action Part A. Identification, Cloning and Characterization of CASZ1, the human homolog of the drosophila neural fate determination gene castor (dCas). 1. The study of CASZ1 is warranted because it; 1) maps to chromosome 1p36.22 a region lost in almost 98% of NB tumors with 1p36 LOH ; 2) was a highly evolutionarily conserved neural fate determination gene; 3) has not been functionally studied in mammalian model systems; 4) is regulated during NB cell differentiation and 5) is expressed at high levels in primary tumors of NB patients with good overall survival (p=0.0009). 2. EZH2 medicated Epigenetic suppression contributes to CASZ1 loss of function in Neuroblastoma. The classic involvement of a suppressor gene in tumorigenesis requires biallelic gene inactivation. For CHD5 the NB SRD 1p36 tumor suppressor, 1 allele is lost via 1pLOH while the remaining allele is silenced via DNA methylation. The finding that in both 1pLOH and intact1p NB cells, CASZ1 expression is induced after HDACi treatment suggests chromatin modifications play a role in suppressing CASZ1 expression. A bioinformatic analysis of the CASZ1 locus indicated that in Embryonic stem cells (ES) the CASZ1 transcriptional start site (TSS) contains a bivalent chromatin mark- an activation mark characterized by acetylation of histone 3 at lysine 4 (H3K4me3) as well a suppressive mark characterized by methylation of histone 3 at lysine 27(H3K27me3). Bivalent marks in ES cells are typically found at genes poised to be dynamically regulated, such as during develoment. Since the enzymatically active EZH2 component of the polycomb repressor complex (PRC2) mediates the H3K27me3 silencing mark, we performed a series of experiments that directly demonstrated that CASZ1 is a target of PRC2 complex mediated suppression. ChIP-PCR analyses indicated that PRC2 complex proteins and an H3K27me3 suppression mark were enriched over the CASZ1 TSS in NB cells under steady-state conditions. After treatment with an HDACi (Depsipeptide), binding of these proteins to CASZ1 TSS decreased, the CASZ1 TSS lost the chromatin silencing H3K27me3 mark and was enriched in a chromatin activation mark H3K4me3. Pharmacologic and genetic inhibition of EZH2 in NB tumor cells increased CASZ1 expression. Moreover, now we have found that the PRC2 complex proteins suppress not only CASZ1, but repress CLU(clusterin), NGFR, p73, Runx3 and TrkA(NTRK1) expression. This identifies PRC2 as mediating suppression of a number of genes with tumor suppressor activity in NB. A perplexing aspect of the biology of NB tumors has been their genetic heterogeneity and their biologic plasticity. This study identifies EZH2 as a potential regulatory mechanism that may link these two aspects and is therapeutically tractable. Part B. Mechanism of CASZ1 Function 1. Structure Function Study identifies critical domains regulating CASZ1 transcriptional activity. Despite prior studies implicating CASZ1 in neural (Drosophila) and heart (Xenopus) development, the key structural domains mediating its transcriptional programs have not been elucidated in any species. Since the CASZ1b isoform is the most evolutionarily conserved isoform, we utilized site-directed mutagenesis and deletion mapping to identify key domains in CASZ1b required to 1) activate transcription of a tyrosine hydroxylase promoter-luciferase (TH-Luc) reporter construct and 2) regulate endogenous transcription of several CASZ1 neural (TH, TrkA, NGFR) or muscle differentiation-associated (MYO7A) target genes. Mutation of the C2H2 motif-defining cysteine to an alanine in any one of ZF1, 2, 3, or 4 caused a 60-80% loss in CASZ1b transactivation activity. Mutation of ZF5 did not. Next, a series of N-terminal truncations revealed a critical activation domain at AA31-185, which despite retaining nuclear localization completely lost transactivation function. Deletion of other predicted domains as well as the region C-terminus up to ZF4 (38% of the protein) had no appreciable effect on CASZ1b activity. Additional deletions of a proline-rich region, ATP binding site and a Peroxisome targeting sequence had modest but variable effects on CASZ1b transcriptional activity. Finally, we engineered the transcriptionally inactive mutant (ZF4deletedCASZ1b) into NB cells and found that it has a 50% decrease in its ability to inhibit NB cell growth compared to the CASZ1WT. We also found that mutations in CASZ1b blocking its transcriptional activity also resulted a decreased ability of CASZ1b to suppress NB tumorigenicity. These data defined important domains mediating CASZ1b's transcriptional activity and demonstrated that the transcriptome regulated by CASZ1 is important in mediating its growth and tumor suppressor properties. 2. CASZ1 inhibits neuroblastoma cell cycle progression by restoring pRb activity. The cell cycle genes cyclin D1 and Chk1 are dysreguated in neuroblastoma and contribute to its undifferentiated phenotype. To understand CASZ1 function as a tumor suppressor gene, we evaluated how restoration of CASZ1 levels affects Neuroblastoma cell cycle progression. Within 8hrs of CASZ1 restoration, there is a 3-fold increase in p21,an inhibitor of G1 cdk2/4 kinases and a 40% decrease in cdk6 levels. CASZ1 restoration activates pRb causing a decrease in E2F mediated transcriptional activity. The CASZ1 mediated decreases in the G1 cyclin dependent kinases is followed by decreases in G2/M cyclin dependent kinases. These alterations lead to a lengthening of NB cell cycle progress and decreases in NB cell proliferation. Lengthening of cell cycle progression is associated with implementation of differentiation programs. By identifying and analyzing the critical domains within this gene, and delineating how CASZ1 affects NB cell cycle progression we are beginning to unravel the molecular mechanisms of regulation of the CASZ1 differentiation program. Not only does this move us one step closer to understanding the potential impact of this gene on neuroblastoma pathogenesis, it provides the first molecular analysis of a gene that has already been shown to be important in neural and cardiomyocte differentiation programs. 3. Casz1 Knock-out leads to murine embryonic lethality due to heart defect To understand CASZ1 function in tumorigenesis we have generated a genetic KO of Casz1 in mice by inserting a B-gal reporter gene in the first intron of murine Casz1 gene. We have also generated a floxCasz1 mouse in order to develop tissue specific KO of Casz1. Biallelic inactivation of Casz1 leads to embryonic lethality by E16. The basic of the lethality is cardiac hypoplasia and a ventral septal defect. In cardiac myocytes, loss of Casz1 lead to anomalies in Z-band formation and cell-cell contact.